L-type channel trafficking and modulation in heart

SUMMARY
Ca2+ influx through voltage-dependent L-type (CaV1.2) channels into cardiomyocytes is a multi-dimensional
signal that mediates excitation-contraction (E-C) coupling, controls action potential duration, and regulates gene
expression. Dysregulation of CaV1.2 causes heart disease, the leading cause of death in the US and worldwide.
β-adrenergic up-regulation of CaV1.2 underlies the positive inotropic response essential for the fight or flight
response. Despite decades of intense focus, the precise molecular mechanisms underlying β-adrenergic up-
regulation of Ca2+ influx via CaV1.2 in cardiomyocytes remained elusive and controversial. In the last funding
period, using an ascorbate-peroxidase (APEX2)-proximity-labeling method, we discovered that under basal
conditions the Ca2+ channel inhibitor Rad, a small G-protein, is enriched near CaV1.2 but is depleted upon
exposure to a β-adrenergic agonist. Our findings fundamentally recast the mechanism for β-adrenergic
regulation of CaV1.2: under basal conditions, Rad inhibits a sub-population of CaV1.2 in cardiomyocytes; upon
adrenergic activation, protein kinase A (PKA) phosphorylates Rad and relieves this inhibition to increase whole-
cell L-type current (ICa,L). The implications of this new model are profound and raise a slew of fundamental
questions that we are uniquely poised to address based on several innovative approaches we have developed
and insights we have attained in the last funding cycle. This renewal application is motivated by the overall
hypotheses that deepened understanding of the precise mechanisms underlying kinase regulation of CaV1.2 via
Rad will not only provide fundamental new insights into cardiac physiology in the fight or flight response and
beyond, but may also be exploited to develop novel positive inotropic agents to combat heart disease. We
combine innovative approaches developed in the Marx (proximity labeling proteomics, knockin mouse models)
and Colecraft (nanobody-based targeted regulation of CaV1.2) labs to address three specific Aims. 1) Elucidate
mechanisms and determinants underlying Rad targeting to CaV1.2 in heart and β-adrenergic regulation of ICa,L.
2) Elucidate mechanisms and physiological role of kinase-phosphatase balance regulation of basal CaV1.2 in
cardiomyocytes. 3) Engineer the kinase-phosphatase balance in the CaV1.2 nanodomain using targeted
recruitment of kinases.

Public health relevance
NARRATIVE The proposal focuses on understanding the molecular mechanisms of L-type calcium channel regulation in heart cells. The studies have potential to provide deepened insights into the molecular basis of cardiovascular diseases and lead to development of better therapies for these diseases.